Harnessing Age-Associated B cells for a Universal Influenza Vaccine for the Aged

ABSTRACT:
Harnessing Age-Associated B Cells for a Universal Influenza Vaccine for the Aged. With age, the
generation of T follicular helpers from naive CD4 T cells, and germinal center B cells from follicular B cells, that
are both needed for the generation of high affinity antibody (Ab), become highly compromised. Most current
vaccines for influenza in the elderly are not effective at inducing these critical responses. Thus, the elderly,
though protected by Ab already in place for pathogens encountered earlier in life, are highly susceptible to new
strains of virus (e.g. influenza) and newly emerged pathogens (e.g. pandemic influenzas, COVID-19). We
described the generation of an unusual population of Ab-secreting B cells that developed to live influenza
infection in aged mice. We found they were derived from stimulation of recently described "age-associated B
cells" (ABC) of a naïve sIgD+ phenotype. In the aged, these influenza-induced ABC (iABC) are generated
independently of CD4 T cell help, but strictly depend on stimulation by pathogen-associated "danger" signals
and thus they are generated well in aged infected mice. Notably, ABC are the predominant naïve B cells that
respond in aged mice.
Here we will determine the potential of IgD ABC to respond to influenza infection and generate Ab-secreting cells
(AbSC) effector iABC that are either recirculating or are tissue resident. We will determine if they give rise to B
cell memory, both resting memory and long-lived Ab-secreting cells, and if these are found in the lower
respiratory tract (lung) and upper respiratory tract (URT):nasal tissues and nasal associated lymphoid tissue-
NALT), as well as the spleen and BM. We will determine the contribution of ABC-derived effector and memory
subsets and the Ab they produce in these the different sites to protection from reinfection. We will ask how long-
lived are the memory cells in distinct sites. We will compare the ability of live influenza virus, whole inactivated
virus, and mRNA-LNP HA vaccine to generate the recirculating and tissue resident effector and memory subsets
and to induce protective immunity. These results will give us new insights into this novel age-associated immune
pathway and give us important new insights into whether harnessing the aged ABC response can provide
superior protection in the aged. It will provide indications of what general vaccine strategies are likely to be
needed to immunize the ABC in the elderly. These findings could lead to a more Universal vaccines that can
provide robust protection to the elderly, who are currently highly vulnerable.

Public health relevance
NARRATIVE Harnessing Age-Associated B Cells for a Universal Influenza Vaccine for the Aged. Recently we found that a unique age-associated B cell (ABC) population that includes naïve IgD+ B cells and generates a unique extrafollicular effector B cell response to influenza infection, is, in the aged, the predominant response producing Ab-secreting cells and Ab to new infections. We will determine the extent to which ABC generate lung and nasal tissue-resident Ab-secreting effectors that give rise to resting memory B cells and long-lived Ab-secreting cells and will determine if vaccines can elicit these responses and if these unique memory cells provide protective immunity. This will inform strategies to make a Universal influenza vaccine that is protective in the aged.